Supplement for Purchase of a Cell Sorter for R35GM133797

PROJECT SUMMARY
Cellular heterogeneity is ubiquitous across all domains of life. Genetically identical cells can
display heterogeneous metabolic activities, even when grown in identical environments. In
bacteria, metabolic heterogeneity can shape the ensemble growth rate and affect antibiotic
tolerance. In bacteria, metabolic heterogeneity shapes the ensemble growth rate and affects
antibiotic tolerance. However, many questions remain regarding metabolic heterogeneity. For
instance, what determines the size of metabolic fluctuation? How is metabolic heterogeneity
regulated? Can we control metabolic heterogeneity and therefore eliminate drug-tolerant cells?
The lack of fundamental understanding has severely limited the development of effective
treatments for multiple diseases in which a small number of transiently tolerant cells often cause
disease recurrence. The current MIRA project aims to obtain a systematic understanding of
bacteria metabolic heterogeneity by using single-cell metabolic analysis methods. Using an
engineered metabolic pathway that produces a unique fluorescent metabolite―betaxanthine, this
project aims to determine the origin, dynamics, and propagation of metabolic heterogeneity.
Furthermore, this project studies how transcriptional regulations affect metabolic heterogeneity,
and explores the influence of metabolic heterogeneity on drug tolerance and strategies to reduce
metabolic heterogeneity.
This Equipment Supplement application requests fund to purchase a new flow cytometer to
replace an old flow cytometer in the PI’s lab that was broken and is not repairable. Flow cytometer
is essential to the parental project in studying metabolite heterogeneity. Obtaining a new flow
cytometer will substantially accelerate the productivity of this project and enable new capabilities
to the PI’s research group to explore new areas in metabolite heterogeneity.

Public health relevance
PROJECT NARRATIVE This project will purchase a new flow cytometer to quantitative measure heterogeneity in gene expression and metabolite abundance, enabling understanding about the causation, and regulation of metabolic heterogeneity in bacteria. The results will help to identify methods to control metabolic heterogeneity that is related to bacterial multidrug-tolerance.